Iowa Department of Agriculture and Land Stewardship LFFM - Expanding Capabilities and Capacities

The Iowa Department of Agriculture and Land Stewardship (IDALS) propose to partner with the FDA with
the Laboratory Flex Funding Model (LFFM) to enhance the capacity and capabilities of state human and
animal food testing laboratories in support of an integrated food safety system. ISO/IEC 17025:2005
laboratory accreditation within the scope must be maintained at full implementation to strengthen
quality results. IDALS compliance of the FDA’s requirements will benefit the FDA by enabling IDALS to
develop and implement standards, develop and maintain best practices, enhance food safety, and
reduce illnesses attributed to various food safety hazards. By maintaining ISO/IEC 17025:2005
accreditation, the data will come from a quality system that delivers results that are recognized as high-
quality, and will be immediately enforceable, thus increasing food security through an integrated food
safety system that is effective and efficient.
IDALS overall strategy to meet the goals of the LFFM is to expand IDALS testing capabilities and capacity
hiring new employees, purchasing additional equipment, validating new methods, and testing human
and animal food samples.

Public health relevance
Iowa Department of Agriculture and Land Stewardship LFFM - Expanding Capabilities and Capacities Narrative This proposal supports an integrated food safety system through expanded microbiological and chemical testing of human and animal food. In addition to expanded testing, new methods will be implemented to add new capabilities and new equipment will be purchased to increase testing capacity. These activities will improve human and animal health by decreasing exposure to foodborne hazards.